Targeting stroke-induced brain swelling in obese subjects: role of VEGF

Project Summary
Stroke is the leading cause of physical disability worldwide and represents a global socioeconomic
burden to human health. Despite an intense research effort that led to a plethora of targets and
neuroprotectants to reduce stroke-induced brain injury in animals, the neuroprotection-based
strategies resulted in little or no efficacy in numerous controlled clinical trials. These observations
indicate that there should be a paradigm shift to enhance the translational efficacy issue and improve
this devastating condition. Potential missing links that account for the translational hindrances include
solely relying on infarct size without considering brain swelling to gauge neuroprotection in preclinical
studies. In addition, there is a paucity of inclusion of risk factors in animal models of stroke, whereas
comorbidities such as dyslipidemia, hypertension, diabetes, and obesity are frequently observed
conditions in patients. The combined evidence supports the conclusion that there is a critical need to
define stroke pathology focusing on brain swelling in metabolically compromised conditions, which is
the overall scientific premise for the proposed research. Our recent findings showed that mice with
diabetes and hyperlipidemia displayed disproportionately larger brain swelling compared to infarct
volume, and the enhanced brain swelling was closely associated with an increased level of vascular
endothelial growth factor receptor 2 (VEGFR2), a key signaling molecule for vascular permeability and
angiogenesis. As obesity is a precipitating cause leading to metabolic disorders including diabetes
and dyslipidemia, we hypothesized that VEGFR2 underlies obesity-enhanced brain swelling in stroke
and that blocking VEGFR2 activation reduces the swelling and promotes functional recovery in
obesity. Aim 1 will identify the role of VEGFR2 activation(s) on stroke-induced brain swelling in obese
mice by assessing histological and molecular outcomes. In Aim 2, the loss and gain of function
studies will evaluate the efficacy of VEGFR2 modulation on obesity-enhanced stroke-induced brain
swelling using pharmacological and genetic approaches. Aim 3 will determine the impact of brain
swelling on long-term stroke recovery by assessing long-term motor and cognitive function in obese
mice where VEGF signaling is manipulated. At the completion of the project, we expect to obtain
scientific evidence establishing the importance of VEGF signaling in obesity-enhanced brain swelling,
the utility of VEGF inhibition as a treatment strategy in obesity stroke, and reducing brain swelling as
an approach to promoting long-term stroke recovery. These results are expected to have a significant
impact by providing strong justification for the repurposing of available VEGF-targeted anti-
angiogenic/anti-cancer drugs to treat stroke patients with obesity and its associated comorbidities.

Public health relevance
Project Narrative While stroke is the leading cause of disability in the U.S., treatment options for stroke patients to reduce post- stroke impairment and/or enhance recovery are very limited. Despite tremendous research efforts, there have been difficulties in translating the positive effects observed in animal studies to clinical settings. The current proposal addresses these challenging issues by including obesity, a prevalent risk factor in an animal model. The proposal is relevant to the NIH's mission because understanding of stroke pathology in obese subjects could lead to the development of agent(s) to treat patients with obesity, a common risk factor.